THE XNAT IMAGING INFORMATICS PLATFORM

Project Summary
This proposal aims to continue the development of XNAT. XNAT is an imaging informatics platform designed
to facilitate common management and productivity tasks for imaging and associated data. We will develop the
next generation of XNAT technology to support the ongoing evolution of imaging research. Development will
focus on modernizing and expanding the current system. In Aim 1, we will implement platform components, in
including a new archive file management system and database interface, a streamlined image annotation
interface, a module to support integrations with cloud applications, and a set of software development kits
(SDKs) to support development of tools that interact with XNAT data and services. In Aim 2, we will implement
two innovative new capabilities that build on the services developed in Aim 1. The XNAT Workspaces module
will link Jupyter Notebooks with XNAT, creating a computing environment that enables users to mount
specified data sets in their Notebooks, share and clone Notebooks, save Notebooks to version control
systems, and publish them as static dashboard. XNAT Workspaces will be linked to XNAT Container Service
and high-performance computing and cloud computing resources to enable scalable computation. The XNAT
Machine Learning (ML) Studio will provide an integrated application for data science teams to build and
annotate data sets, train and validate ML models, and publish their models as deployable applications. ML
Studio will implement quality control, logging, and provenance tracking to help users avoid the pitfalls that often
plague machine learning efforts. For both Aim 1 and 2, all capabilities will be developed and evaluated in the
context of real world scientific programs that are actively using the XNAT platform. In Aim 3, we will provide
extensive support to the XNAT community, including developer workshops and hackathons, online
documentation, discussion forums, and the XNAT Academy training platform. These activities will be targeted
at both XNAT users and developers. Together these aims represent a major advance in imaging informatics
that is unique in the field and will greatly benefit an extraordinarily broad research portfolio.

Public health relevance
Project Narrative Medical imaging is one of the key methods used by biomedical researchers to study human biology in health and disease. The imaging informatics platform described in this application will enable biomedical researchers to capture, analyze, and share imaging and related data. These capabilities address key bottlenecks in the pathway to discovering cures to complex diseases such as Alzheimer’s disease, cancer, and heart disease.